The role of microvesicles in promoting cell growth, survival and differentiation

DESCRIPTION (provided by applicant): Cell-to-cell communication is a fundamental process in cell biology that is necessary for proper development and tissue homeostasis. When deregulated, it can also lead to developmental abnormalities and human diseases, such as cancer. In recent years, microvesicles (MVs) have emerged as a novel form of cell-to-cell communication that is frequently used by cancer cells to promote the malignant state. Specifically, MVs are small (0.1-2 μm) vesicular structures that are derived directly from cell plasma membranes and are shed into the cells' surrounding environment. MVs have the ability to fuse to other cells and transfer cargo such as signaling proteins, mRNAs, and miRNAs. The sharing of cancer cell- derived MV cargo with normal cells has been shown to induce the transformation of the normal cells, and this raised the possibility that other cell types, such as embryonic stem (ES) cells and differentiated cells, might also generate MVs and use them to alter the behavior of neighboring cells. Indeed, feeder layer- independent mouse ES cells and differentiated cells derived from these ES cells generate and shed MVs, and a mass spectrometry analysis of ES cell-derived MVs revealed that they contain many proteins, including cytoskeletal components and transcription factors. Preliminary findings suggest that ES cell MVs, when isolated and then added to cultures of serum-starved NIH3T3 fibroblasts, can promote the survival of fibroblasts, while MVs derived from differentiated cells may be able to enhance the differentiation of ES cells into specific cell lineages. The primary focus of this investigation is to better understand this novel form of cellular communication by determining how specific cargo is trafficked into the MVs and to elucidate the biological effects and mechanisms of both ES cell and differentiated cell MVs on cell growth, survival, and differentiation. To this end, the following lines of investigation will be carried out: 1) Determin the biological actions of ES cell- and differentiated cell-derived MVs on the growth and survival of ES cells and normal cells. In addition, the effects of both types of MVs on the differentiation f ES cells will be examined. 2) Determine the mechanism behind the biological effects of the MVs derived from ES cells and differentiated cells. In this aim, emphasis will be placed on identifying the protein component(s) of the MVs that promote the survival of other cells. 3) Determine the methods by which proteins are trafficked into the MVs of ES cells and differentiated cells. Given that the ES cell MVs contain components of the microtubule trafficking network, microtubule trafficking will be examined as a potential regulator of the protein content of MVs. These studies will further the understanding of MVs, a novel form of cell-to-cell communication, in the context of ES cells and differentiated cells. This will enhance our knowledge of cell- to-cell communication and provide insights that could be of great value to regenerative medicine.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cell-to-cell communication is vital for development and tissue maintenance, while deregulation or alterations in cell-to-cell communication can lead to a variety of developmental abnormalities and human diseases, such as cancer. Microvesicles (MVs) represent a unique form of intercellular communication, where membrane-enclosed "packets of information" are shared between cells, and while MVs are being intensely investigated for their roles in promoting cancer progression, I have recently found that embryonic stem cells also generate MVs, raising the intriguing possibility that this novel form of cell communication also plays critically important roles in embryogenesis and development. The aims in this grant are designed to provide important insights into how stem cells as well as their differentiated cellular lineages use microvesicles for critical cell-to-cell communication, with the expectation that the results of these studies will be highly relevant both to fundamental biological processes and to regenerative medicine. __SpecificAimsTextDelimiter__ Specific Aims The recent discovery that aggressive forms of cancer cells generate and shed large (0.1-2 μm) unconventional vesicles from their surfaces, called microvesicles (MVs), has spawned tremendous interest in the signaling and cell biology communities.1,2 This is largely due to the fact that these MVs contain cargo ranging from cell surface receptor tyrosine kinases and cytosolic signaling proteins to RNA transcripts and microRNA.3-5 Notably, only a subset of cellular proteins and RNA transcripts are enriched in MVs,2,4 suggesting that the trafficking of cargo into MVs is a selective process. The MV cargo can then be transferred to recipient cancer cells where it induces signaling events that promote cell growth and survival.5 Moreover, our laboratory has shown that MVs shed from cancer cells, when added to normal fibroblasts or epithelial cells, confer upon these recipient cells the properties of a transformed cell. This occurs by hyper-activating integrins expressed on the surfaces of the recipient cells via large amounts of the extracellular matrix protein fibronectin (FN) contained on the cancer cell MVs.6 Thus, the MV-mediated transfer of cargo between cancer cells or between cancer cells and nearby normal cells (such as those in the tumor microenvironment) could contribute to cancer progression. Recently, I have made the exciting discovery that mouse embryonic stem (ES) cells, as well as differentiated cell types derived from ES cells, also shed MVs from their surfaces, raising the possibility that the generation of MVs is a process inherent to all cells. Moreover, I have found that MVs derived from ES cells promote the survival of normal fibroblasts, similar to cancer cell MVs. Mass spectrometry analysis revealed that ES cell MVs contain a range of components including transcription factors, cytoskeletal proteins and cytoskeletal-related motor proteins, and extracellular matrix components, indicating that the transfer of MV cargo to a recipient cell could have pleiotropic effects. In particular, FN, and several proteins linked to pluripotency, including Oct3/4, Sox2, Klf4 and c-Myc,7 are all found in the ES cell MVs. As for the MVs derived from differentiated cells, my preliminary data suggests that adding MVs shed from cardiomyocytes to ES cells enhances their ability to differentiate into the same lineage. These findings suggest that MVs are not only important for promoting the survival of a cell population, but also for the efficient differentiation of ES cells, which may have important implications in regenerative medicine. By carrying out the aims below, I will build upon my findings that ES cells and differentiated cells generate MVs by determining whether MVs serve as "satellites of communication" that transfer cargo between cells as a way to enhance cellular differentiation as well as cell growth and survival. In addition, I will determine the protein components of the MVs that mediate these biological effects. Finally, I will begin to identify the mechanisms that regulate the trafficking of cellular components into MVs. I expect that these studies will provide novel insights into a poorly understood but potentially important connection between MVs and the growth and ultimate differentiation of ES cells into specific cell lineages. Aim 1. Determine the biological functions of MVs derived from ES cells and differentiated cells. Since MVs derived from cancer cells promote the growth and survival of normal cells by transferring their cargo to recipient cells,6 I will first read out the ability of MVs shed by ES cells versus those shed by differentiated cells to transfer cargo to recipient cells by labeling the MVs with a plasma membrane- targeted GFP construct. Then, I will determine whether MVs derived from both ES cells as well as those shed by differentiated cells are able to promote the growth and survival of ES cells and normal fibroblasts. I will also determine whether MVs from either ES cells or differentiated cells can influence the differentiation of ES cells into specific cell types. Aim 2. Determine the protein components of MVs that mediate their biological effects. ES cell-derived MVs promote the survival of normal fibroblasts and are enriched in FN, an extracellular matrix protein, which was shown to mediate the growth and survival capabilities of cancer cell MVs.6 Therefore, I will determine if FN is also necessary for the ability of ES cell MVs to promote cell survival. If FN does not play such a role, other proteins expressed in these MVs, including several pluripotent markers found in the MVs, will then be tested. If MVs derived from differentiated cells also promote the survival of normal fibroblasts (Aim 1), I can examine additional candidates by identifying proteins that are common to MVs derived from both ES cells and differentiated cells. Aim 3. Determine the mechanisms regulating the trafficking of cellular components into MVs. The trafficking of proteins and RNA cargo into MVs is a selective process,2 but little is known about how specific cargo is transported into MVs. Therefore, as a longer-term goal, I will set out to determine the mechanisms underlying the selective trafficking of cargo into MVs. Given that ES cell MVs contain components of the microtubule trafficking system, which transports cargo to multiple cellular locations,8 I will first examine the potential role of microtubules in the transport of cargo into MVs.